How transcription disrupts genome 3D organization

Title:
How transcription disrupts genome 3D organization
Abstract:
The 3D packaging of chromatin within the nucleus plays an important role in regulating gene expression.
While the principles of how the genome is folded in the nucleus are increasingly well understood, we know
remarkably little about the mechanisms that drive dynamic changes in genome 3D structure, e.g. during
differentiation. We recently discovered that influenza A infection inhibits transcription termination, resulting in
read-through transcription often extends hundreds of kilobases past the 3’ ends of genes. Transcription of
these regions disrupts local cohesin-mediated chromatin interactions, leads to chromatin decompaction and
frequently induces switching of previously inactive genome regions to the active compartment. These
compartment changes occur in a matter of hours, and in the absence of epigenetic changes, which usually
are found to correlate with compartment association of a locus. Further analysis of genic transcription
revealed that cohesin loss is closely temporally linked to RNA polymerase II arrival at cohesin binding sites,
suggesting that RNA polymerase II itself is involved in displacing cohesin from chromatin. To study these
phenomena in detail, we will comprehensively characterize the epigenetic and transcriptional effects of
pervasive read-through in degron-tagged cell lines as an alternative model for transcription-induced genome
3D structure changes, and test the contribution of gene structure to delimiting where RNA polymerase II
transcription changes genome organization. In a separate set of experiments, we will use a candidate
approach to identify proteins involved in transcription-associated cohesin unloading. These studies will help
reveal how transcription influences chromatin interaction and increase our knowledge of the mechanisms
that dynamically reorganize genome 3D organization.

Public health relevance
Project Narrative This project examines the role that the fundamental process of transcribing the genome plays in shaping the genome’s 3D structure in the cell nucleus. It addresses a gap in our knowledge about the mechanisms that change the how the genetic information in the nucleus of our cells is organize. This organization plays central roles in the development of our body, and has direct relevance in aging and diseases that undermine the identity of a cell such as cancer and viral infectious diseases. Starting from the finding that gene transcription can change the organization of the genome by breaking up protein complexes that tie the different parts of a chromosome together, our study characterizes what happens when transcription doesn’t stop at the end of genes, but rather continues to transcribe into previously tightly packed genome regions. This research has the potential to contribute major conceptual advances to our understanding of how the genome works.